Membrane cholesterol and vascular inflammation

ABSTRACT
Our long-term objective is to define cellular pathways that regulate lipid flux and to elucidate their impact on
cardiovascular disease. Although the connection between hypercholesterolemia and vascular inflammation
has been appreciated for decades, the mechanistic underpinnings of this association remain incompletely
understood. This application builds on recent work that defined mechanisms of nonvesicular lipid transport
and identified pathways to regulate PM cholesterol abundance in experimental systems. We showed that the
Aster transporter family facilitates the movement of cholesterol from PM to ER, and that loss of Aster function
leads to PM cholesterol accumulation. But the role this transporter in vascular physiology is completely
unknown. Preliminary observations have revealed that Aster-A is responsive to inflammatory activation of
endothelial cells (ECs), and suggested that loss of Aster function modulates vascular inflammation through
control of PM cholesterol availability. We have further discovered that cholesterol binds directly to endothelial
PM proteins, including ICAM-1 and VCAM-1, pointing to a novel mechanism by which changes in PM lipid
composition may determine inflammatory responses. Specific Aim 1 will identify novel cholesterol-responsive
proteins in the vasculature using chemical biology. Provocative early results have revealed that multiple cell
surface proteins involved in vascular inflammation bind cholesterol directly and are responsive to changes in
PM cholesterol. We will define the spectrum of cholesterol-binding proteins in ECs in response to
hypercholesterolemia and in settings of vascular inflammation. Specific Aim 2 will define molecular
mechanisms whereby membrane cholesterol regulates inflammatory signaling in vascular cells. We will
determine how changes in PM accessible cholesterol affect signaling by membrane inflammatory receptors
and elucidate how the physical interaction of cholesterol with endothelial adhesion molecules regulates their
abundance. Specific Aim 3 will elucidate the impact of accessible PM cholesterol on vascular inflammation
and cardiovascular disease. We will use Aster-A loss-of-function models to manipulate accessible PM
cholesterol in cultured ECs and in animals.

Public health relevance
Project Narrative We have identified novel cholesterol-binding proteins in endothelial cells involved in the control of vascular inflammation. We will define mechanisms whereby changes in accessible plasma membrane cholesterol levels regulate inflammatory signaling in the setting of cardiovascular disease. These studies are expected to provide fundamental insight into pathways regulating cholesterol homeostasis and may suggest opportunities for modulating cardiovascular inflammation.